Pharmacogenomic Evaluation of Antihypertensive Responses

DESCRIPTION (provided by applicant): Hypertension (HTN) places over 70 million Americans (and approximately one billion individuals worldwide) at substantially increased risk for stroke, heart attack, renal failure, and heart failure, and is the most common chronic disease for which medications are prescribed. There are numerous acceptable first line treatment options for HTN, yet selection of a specific drug for a given patient is empiric, only about 50% of patients have acceptable blood pressure (BP) lowering with a given antihypertensive drug, some experience adverse metabolic effects and develop diabetes, gout or metabolic syndrome as a result of their therapy, and individual long-term outcomes vary despite equivalent BP lowering. Pharmacogenomics offers the clinical potential for individualized therapy based on genetic make-up. We propose genetic variability plays an important role in the effects of antihypertensive drugs, including their BP lowering, adverse metabolic effects, and their influence on clinical outcomes. Our overall aims are to discover, replicate and define the mechanistic basis for genetic determinants of the BP lowering responses, adverse metabolic responses and long-term clinical outcomes (death, stroke, heart attack, diabetes) to two commonly prescribed classes of antihypertensive drugs, thiazide diuretics and p-blockers. Our approach will also provide insight into the consistency of genetic associations we study across drugs within a class (i.e. the drug class effect). Specific Aims 1 and 2) Using PEARI data, discover genetic determinants of antihypertensive and adverse metabolic responses (glucose, triglycerides, uric acid) to thiazide diuretics and (31-selective blockers. We will replicate findings in variety of thiazide and p-blocker-treated cohorts through established international collaborations. Additionally we will conduct a 400 subject randomized crossover study of metoprolol and chlorthalidone for additional replication and to establish a class effect for the genetic associations. Specific Aims 3 and 4) Using the INVEST-GENES clinical trial cohort, identify genetic predictors for prevention of death, heart attack, stroke and new-onset diabetes with p-blocker+thiazide therapy, followed by replication in the ASCOT clinical trial genetic cohort. Specific Aim 5) Define functional polymorphisms and their mechanistic basis for Aim 1-4 discoveries. Specifically: 5a. Resequence genomic regions of interest in individuals sampled from the clinical response phenotype extremes, and 5b. Investigate causal mechanisms for differential gene expression, using a variety of sophisticated molecular genetic experimental approaches. Discoveries from this work could lead to genotype-guided selection of antihypertensive drugs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Hypertension (HTN) affects about 75 million Americans, or 1 in 3 adults. Many effective drugs are available to treat HTN, but individual responses vary. We will study genetic factors that influence BP lowering, adverse metabolic responses, long-term risk for diabetes and prevention of adverse cardiovascular outcomes like heart attack and stroke for two commonly used drug classes, p-blockers and thiazide diuretics In the future genetic information might be used to guide selection of drug therapy for individual patients. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS HTN is the most common chronic disease in the US and the world, it is a major risk factor for stroke, CHD, renal failure, and heart failure, and it is the most common chronic disease for which medications are prescribed. Antihypertensive therapy aims to reduce BP to normal levels and represents the major therapeutic approach for prevention of the adverse sequelae of HTN. Each of the five first-line antihypertensive drug classes (thiazide diuretics, p-blockers, ACE inhibitors, angiotensin receptor blockers (ARBs) and CCBs) has documented efficacy at lowering BP, and each drug class has been shown to significantly reduce adverse CV events associated with HTN.^^ Thiazide diuretics and p-blockers can also produce AMEs (e.g. glucose, triglycerides, uric acid). While there are numerous acceptable first line treatment options for HTN, selection of a specific drug for a given patient is empiric, only about 50% of patients have acceptable BP lowering with a given antihypertensive drug, some experience adverse metabolic effects and develop diabetes, metabolic syndrome or gout as a result of their therapy, and individual long-term outcomes vary despite equivalent BP lowering. Pharmacogenomics offers the clinical potential for individualized therapy based on genetic make-up. We propose a comprehensive approach to antihypertensive pharmacogenomics, whereby we will discover and replicate genetic determinants of the intermediate phenotypes of antihypertensive drug effects, namely BP lowering and AMEs, along with the longer term clinical outcomes, namely death, myocardial infarction, stroke and development of diabetes. These efforts will be followed by resequencing in extreme responders/nonresponders and molecular genetics experiments aimed at deciphering the functional polymorphism and the molecular mechanisms that underlie the genetic associations. Using a two-stage, replication analysis design for aims 1 through 4, we propose the following: Specific Aim 1) Identify genetic determinants of antihypertensive responses to thiazide diuretics and p i - selective blockers. We hypothesize BP response to antihypertensive drugs is variable by genotype and these associations are consistent with the drug class. Specific Aim 2) Identify genetic determinants of the adverse metabolic effects of thiazide diuretics and p i - blockers, namely adverse changes in glucose, triglycerides and uric acid. We hypothesize genetic polymorphisms are important determinants of the adverse metabolic responses to thiazide diuretics and p1-blockers. Specific Aim 3. Identify genes/SNPs associated with adverse CV outcomes (death, myocardial infarction, stroke) during drug therapy with a p-blocker (+ thiazide diuretic) vs alternate therapy (CCB + ACE inhibitor). We hypothesize the protection afforded by antihypertensive drug therapy against death, myocardial infarction and stroke is variable by genotype. These genetic factors may be the same that influence the BP response (as discovered in Aim 1) or may work through mechanisms independent of the BP lowering effects of the drugs, and so may be genetic markers specific to the drug-associated outcomes. Specific Aim 4. Identify genes/SNPs that influence the risk for developing diabetes during drug therapy with a p-blocker (+ thiazide diuretic) vs. a diabetes risk neutral/protective regimen. We hypothesize genetic factors contribute to a patient's risk for developing diabetes during antihypertensive therapy. These genetic factors may be the same that influence the AMEs assessed in Aim 2, a concept our experimental approach will allow us to assess. Specific Aim 5. Based on findings arising from Aims 1-4, define functional polymorphisms and their mechanistic basis by: 5a. Resequencing genomic regions of interest in individuals sampled from the clinical response phenotype extremes and by using a combination of association and bioinformatics approaches to identify likely functional polymorphisms. 5b) Investigating causal mechanisms for differential gene expression, using a variety molecular genetic experimental approaches. We hypothesize that resequencing and molecular genetics approaches focused on differential expression will allow us to move from replicated tagSNPs to identification of functional polymorphisms and their mechanistic basis. Aims 1-4 will be accomplished in a similar manner, using a two-stage discovery/replication analysis approach, followed by studies aimed at determining the functional, molecular genetic basis for the strongest genetic associations. PEARI clinical phenotype data, and genotype data from the 50K CVD chip and the Illumina HumanOmnil-Quad genome-wide array will be utilized for discovery of genetic determinants of response in Aims 1 and 2. Replication studies will be conducted using existing data from an international group of collaborators along with additional data generated in a clinical study to be conducted during the proposed funding period (PEAR2). Discovery of genetic determinants of outcomes for Aims 3 and 4 will occur using the International Verapamil SR-Trandolapril Study Genetic Substudy (INVEST-GENES) clinical trial data with genotype data arising from the 50K CVD SNP array. Replication studies will be conducted in the genetic cohort of the Anglo-Scandinavian Cardiac Outcomes Trial (ASCOT).